Variability of Brain Reorganization in Blindness

PROJECT SUMMARY
Severe vision loss affects ~40 million people worldwide1 and more as the population ages3. The success of sight
restoration and use of sensory aids for blind individuals depends on poorly-understood factors: some people do not
gain functional sight despite invasive procedures37-40. Mitigating this problem requires mapping the impacts of reduced
vision on the brain, which may preclude rehabilitation efforts. Following early-onset blindness, the visual cortex (VC)
undergoes plastic reorganization4-6,14,17 that may crucially affect its capacity to process restored vision and employ
compensatory strategies24. However, little effort has been made to understand the variability of brain reorganization
across blind individuals and its implications for sight restoration and compensatory abilities. Contributing to improved
individually-tailored visual rehabilitation, we propose to study multi-scale variability in the brains of blind individuals
using temporal, neurochemical, and spatial analyses of neuroimaging and behavioral data.
First, we will study if the blind VC retains a higher-than-typical plasticity potential with neurochemical and temporal
dynamics fMRI measures. Since visual experience in early development facilitates VC stabilization42,79, and short-term
dark exposure elicits plasticity41,80,81, we predict sustained plasticity in blind individuals. This would clarify mechanisms
of brain maturation and the potential to harness and revive adult plasticity for rehabilitation.
Second, we will investigate how visual experience affects individual differences in brain development, testing if
blindness results in more variable brain organization. Assessing brain-wide connections of the blind VC and its atypical
responses to non-visual tasks, we will test if VC plasticity affords more variable outcomes which can explain
contradictory group-level findings about VC role in blindness. We will examine the pattern of VC compensatory
engagement in blindness, testing whether plasticity in blindness can change typical VC sensory functions for higher-
level cognitive roles or if it is restricted by neuroanatomical limitations, clarifying the capacity for plasticity in the human
brain.
Finally, we will determine if VC has a single consistent role in all blind individuals or if distinct individual patterns
emerge, patterns that could be employed for individualized rehabilitation. We will examine whether unique and
longitudinally-stable whole-brain patterns of plasticity relate to compensatory behavioral abilities in blind individuals for
touch82-84, hearing63,85-87, memory88-92 and language93,94 and to VC non-visual recruitment. We will further use such
individual plasticity patterns to predict which blind individuals may benefit from a sensory aid (sensory substitution),
revealing if different subtypes of plasticity can indicate behavioral capacities across individuals and be employed as
rehabilitation biomarkers.
Overall, this project will improve our understanding of brain plasticity principles in blindness, and open a path to
defining biomarkers for personalized treatments for visual impairment.

Public health relevance
PROJECT NARRATIVE The ability of blind individuals to regain sight through medical interventions and to use compensatory/assistive technologies varies greatly and is hard to predict, in part due to changes in the blind brain that may prevent it from processing sight efficiently later in life. With our team’s expertise in assistive technologies, advanced neuroimaging techniques and mechanisms of brain plasticity, we will investigate individual differences across scales in the brains of blind individuals, revealing key insights into how the brain develops and matures across different individuals. We will explore how individual profiles of brain plasticity relate to compensatory abilities, aiming to enable personalized treatments from unique neurobehavioral fingerprints which will improve the success of sight restoration outcomes for millions of blind individuals.